Understanding the relationship between codon optimality and mRNA stability

Project Summary
Messenger RNA transmits genetic information from DNA to protein. The regulation of mRNA
levels is a fine balance between transcription rate and degradation rate. Transcriptional control
is well documented and studied. Although the major pathways in mRNA turnover have been
identified, accounting for disparate half-lives has been elusive. My lab has shown that codon
optimality is a general feature that contributes greatly to mRNA stability in eukaryotes. Codon
optimality reflects the disproportionate rate by which the ribosome deciphers each of the 61
codons. The randomness of tRNA selection during the mRNA decoding process manifests in
codon optimality wherein tRNA concentrations/functionality dramatically influence rate.
Accordingly, codon optimality is ultimately gauged by the relative prevalence of cognate tRNAs,
wherein a codon is deemed `optimal' when tRNAs are in excess and conversely `non-optimal'
when tRNAs are more limiting. Codon optimality is also determined by the thermodynamic
stability of codon/anticodon pairing. Our major advance has been to show that the mRNA
degradation machinery monitors ribosome speed and responds to degrade message when
ribosome movement is relatively slow. In this proposal, we investigate how the mRNA
degradation complex senses ribosome translocation rate as a function of codon optimality. We
will determine the precise molecular events that occur in response to ribosome hesitations.
Moreover, we focus on biological context where codon optimality is regulated both through
mRNA chemical modification and tRNA regulated expression. Lastly the influence of codon
optimality is now seen to be the major determinant of mRNA stability in yeast and in early
development. Thus work through this project has uncovered a central and critical principle in
biology that contributes broadly to gene expression regulation.

Public health relevance
Project Narrative My lab discovered that the genetic code not only determines what information is within a gene but also how the message from that gene is read (how long it is read and how fast it is read). This becomes critical in understanding how all of these messages are coordinated by the cell to achieve higher order function. Cancer and viruses (such as H1N1 and SARS-coV-2) may also tap into these principles discovered by my lab, using the hidden information that is within the genetic code to take over cellular function.